Finding the missing parts of human genetics of substance use disorders

Abstract
Substance use disorders (SUDs) are leading causes of death and disability worldwide. A better understanding
of the genetic mechanisms underlying SUD risk could improve their diagnosis, prevention, and treatment,
ultimately reducing the costly and disabling addiction-related problems. Recently, substantial progress has
been made in identifying genetic variants associated with SUDs through gene discovery efforts, particularly
genome-wide association studies (GWAS) in large cohorts. Although these findings considerably advance our
knowledge of SUD genetics, key questions remain unanswered. Current GWAS studies predominantly rely on
SNP arrays and post hoc imputation to identify common variants, leaving certain genomic regions unexamined
due to technical limitations. Whole-genome sequencing (WGS), which can detect both common and rare
variants in large cohorts, offers the potential to recover much of the missing heritability. However, to our
knowledge, no large WGS study of SUDs has been conducted to date. Another significant gap is the estimated
SNP-based heritability of SUDs is low, and as a result, polygenic risk scores (PRS) based on common variants
have limited predictive power in independent cohorts. While statistically significant, these PRS are numerically
weak and not yet clinically useful. To address these gaps and respond to the Cutting-Edge Basic Research
Awards, we propose an innovative study using publicly available WGS data on SUDs from biobanks such as
the All of Us and UK Biobank. This project aims to leverage large-scale WGS datasets to identify novel rare
and common variants associated with SUDs and recover missing heritability (Aim 1). Additionally, the study
will enhance disease prediction through the development of a novel whole-genome multi-ancestry PRS
framework (Aim 2). The proposed research is both timely and aligned with the National Institute on Drug
Abuse's mission. It will substantially enhance our understanding of the genetic architecture of SUDs and lay
the groundwork for the development of precision interventions to prevent and treat alcohol-related diseases.

Public health relevance
Project Narrative Genome-wide association studies (GWAS) of substance use disorders (SUDs) using genotype array data cover only a subset of the genome, leaving many variants unexamined. This project aims to leverage large- scale whole-genome sequencing (WGS) data to identify novel genetic targets, recover the missing heritability of SUDs, and develop a novel whole-genome polygenic risk score framework to enhance predictive accuracy. This proposal represents a new direction in understanding the genetic mechanisms of SUDs using WGS data.